Synthesis and Pharmacological Evaluation of 5-Hydroxy-2-(2- phenylethyll)chromone Analogues

(7) PROJECT SUMMARY/ ABSTRACT:
Glutamate (Glu) is a key excitatory neurotransmitter of the central nervous system (CNS) and plays a significant
role in synaptic plasticity, learning and memory. When synaptic concentrations of Glu increase beyond 1μM,
overstimulation of Glu receptors initiates an irregular rise in intracellular calcium leading to a cascade of negative
cellular responses resulting in neuron death. This process is formally known as glutamate excitotoxicity.
Glutamate excitotoxicity has been shown to be a common pathology in glaucoma, amyotrophic lateral sclerosis,
and Alzheimer’s, Parkinson’s, and Huntington’s disease. As such, approaches designed to prevent glutamate
excitotoxicity would be beneficial for the treatment of many neurodegenerative disorders. 5-Hydroxy-2-(2-
phenylethyl)chromone (5-HPEC) was shown to prevent glutamate excitotoxicity; however, its mechanism of
action is unknown. Studies from our lab have revealed for the first time that 5-HPEC can act as a low affinity 5-
HT2B antagonist and significantly reduces neuronal loss in a Caenorhabditis elegans (C. elegans) model of
glutamate excitotoxity. The hypothesis for this proposal is the 5-HPEC scaffold can be used to design and
develop selective and potent 5-HT2B antagonists with improved neuroprotective activity against
glutamate induced excitotoxicity. Two aims have been proposed to test this hypothesis.
Aim 1: Design, synthesize and characterize 5-hydroxy-2-(3-phenylpropyl)chromone analogues as 5-HT2B
receptor antagonists. Preliminary structure activity relationship studies showed C-2 alkyl chain homologation
of 5-HPEC to 5-hydroxy-2-(3-phenylpropyl)chromone (5-HPPC) improves affinity at 5-HT2B 10 fold. Ligand
docking studies of 5-HPPC using the available 5-HT2B crystal structure identified six positions on the 5-HPPC
scaffold most likely to influence binding affinity. Aim 1A is to synthesize 40 new analogues based on results from
the molecular modeling studies. Synthetic routes executable by undergraduates have been devised to obtain
the proposed analogues. Aim 1B will determine the affinity, selectivity, and functional activity for these
compounds at 5-HT2B. For compounds with improved receptor pharmacology over 5-HPPC further assays will
be used to characterize them as agonist, partial agonist, or antagonist at 5-HT2B.
Aim 2: Determine neuroprotective activity of the newly synthesized ligands. Using an established C.
elegans model of glutamate excitotoxicity we were able to show administration of 5-HPEC at 22mM
significantly reduces neuronal loss due to glutamate excitotoxicity. The goal of this aim is to examine the
neuroprotective activity of the synthesized compounds in these animals. In Aim 2A the average number of
necrotic head neurons per animal will be determined using differential interference contrast microscopy. In Aim
2B differences in locomotor activity due to neuronal loss between treated and untreated animals will be
compared. Compounds showing improved ligand pharmacology at 5-HT2B should reduce neuronal loss and
improve locomotor activity.

Public health relevance
(8) PROJECT NARRATIVE Glutamate excitotoxicity has been identified as a key cellular pathway leading to neuronal death in many neurodegenerative diseases, yet no clinically viable options are available to prevent it. 2-(2- phenylethyl)chromones have shown significant neuroprotective activity against glutamate excitotoxicity but their potential as neuroprotectants remains underexplored. This proposal seeks to develop the promise of this class of compounds by synthesizing a small library of compounds, screening them for their neuroprotective activity, and correlating their neuroprotective activity to their functional activity and affinity for the serotonin receptor 2B.